Combating Breast Cancer Brain Metastasis by Blocking the Two-Pronged Driver Kinase Function of CDK5

Among the 1.6 million women diagnosed with breast cancer every year, 10-16% develop brain metastases
who have a devastating <20% one-year survival. At present, no effective drug treatment exists for patients with
breast cancer brain metastasis. Therefore, effective therapies are urgently needed for this population.
Unfortunately, developing effective therapies for brain metastasis is largely hampered by a lack of in-depth
understanding of the biological mechanisms of brain metastasis, which could guide drug development and
clinical trials. To surmount this challenge, we have performed an in vivo human kinome screen to uncover
novel kinases that promote breast cancer brain metastasis in mice. Kinases are at the central nodes of cancer
cell signaling networks critical for cancer progression and metastasis, and can serve as druggable therapeutic
targets. Among them, cyclin-dependent kinase 5 (CDK5) was a top “hit”, with >26-fold enrichment. CDK5, a
non-canonical CDK, can increase cell proliferation, migration, and angiogenesis. CDK5 overexpression (+++)
significantly correlated with high grade breast cancer and lower survival in patients, but its function in brain
metastasis was overlooked. Thus, we further examined CDK5 function in brain metastasis and found that
CDK5+++ cells a) confer increased brain metastasis and decreased survival in mice; b) can adapt to, and
proliferate in, low glucose and hypoxic culture condition that mimics the environment in the brain; c) induce
immunosuppression by down-regulating MHC class I (MHC-I). Conversely, mice-bearing brain metastases of
CDK5 knockdown tumor cells had prolonged survivals. Attractively, CDK5 is readily targetable with clinically-
applicable, blood-brain-barrier penetrating inhibitors. Here, we hypothesize that CDK5 activation promotes
breast cancer brain metastasis by both facilitating cancer cell adaptation/outgrowth in the brain and by
immunosuppression; CDK5 inhibitors may be developed as new therapeutics for breast cancer brain
metastasis. The major goals of this proposal are 1) Determine the brain metastasis-promoting functions of
CDK5 in spontaneous brain metastasis models and in immune competent mouse models, and examine its
clinical relevance in patient specimens; 2) Explore novel mechanisms of CDK5-enhanced brain metastasis by
examining the impact of CDK5+++ in cancer cells on both a) breast cancer cell adaptation/outgrowth in the
brain and b) inducing immune suppression; 3) Evaluate the potential of targeting CDK5 for early intervention
and treatment of brain metastasis to prolong mouse survival. The successful completion of these studies will
bring about new understanding of breast cancer brain metastasis and the first generation of effective brain
metastasis-targeted therapies. Ultimately, our findings will be translated to clinical trials, leading to new and
better treatments for breast cancer patients having brain metastasis.

Public health relevance
This R01 application tackles one of the most challenging problems in the cancer field: NO effective drug treatment exists for patients with brain metastases. The major goal of this research is to determine whether and how CDK5, identified from our in vivo kinome screen, promotes breast cancer brain metastasis, and whether clinically-applicable inhibitors of CDK5 may be rapidly developed as new therapeutic agents for brain metastasis. Our research findings will be smoothly translated to clinical trials, leading to new and better treatments for breast cancer brain metastasis to enhance the quality of life and prolong survival of patients suffering from brain metastasis.